HIV-specific nucleases to reservoir cells

DESCRIPTION (provided by applicant): Despite the success of current anti-HIV drugs, which can often reduce levels of virus in a patient to undetectable levels, the drugs do not cure people of HIV, so that virus levels rapidly rebound if a patient stops taking the drugs. The major reason for this failure is that low levels of latent or reservoir HIV remain despite the drug treatment, hiding out in long-lived and quiescent cells such as central memory T cells. Strategies that removed this residual reservoir could complement current antiretroviral therapies and allow for the eventually cure of infected individuals. Here, we describe an approach to reduce the latent reservoir through the targeted delivery of HIV-specific nucleases to a key subset of cells that has been shown to be enriched in latent HIV genomes. The approach uses emerging technologies based on targeted nucleases and engineered viral vectors, and will be evaluated using in vivo models of HIV latency. In this way we propose to develop a new class of therapeutics that could contribute to the management of HIV infection and the goal of a cure.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIV infection can be treated but not cured by current anti-HIV drugs. This means that patients must take these drugs for life, with the accompanying expense, and there is always a risk of side-effects or viral resistance developing. New ways to treat people that produced an actual cure would have great medical and economic benefits.